Elucidating the role of CHI3L1/YKL-40 in Alzheimer’s disease

PROJECT SUMMARY/ABSTRACT
Chitinase-3-like protein 1 (CHI3L1/YKL-40) is a well-known biomarker for the early detection of
neuroinflammation and Alzheimer’s disease (AD). It acts as a master regulator of immunity in peripheral tissues,
engaging defined cell surface receptors to regulate a wide range of injury and repair responses. In the brain,
CHI3L1 is primarily secreted by astrocytes and indicates the reactive, neurotoxic state triggered by inflammation
and other stress. The association with CHI3L1 expression and AD pathological and clinical manifestations is well
established, but the exact mechanism by which CHI3L1 contributes to AD pathogenesis is still unclear. The
dynamic interactions between microglia, astrocytes and neurons are central in the inflammatory neurotoxicity
that leads to neurodegeneration in AD. Understanding the intricate cellular cross-talk in human neural systems,
as well as the role of CHI3L1 in this process, thus signifies a critical need for developing therapeutics for AD.
Using human stem cell-based methods and original transgenic mouse models, the overall objectives are
twofold: i) to define the signaling mechanism whereby CHI3L1 governs neurodegeneration caused by glial
activation; and ii) to develop the translational potential of these signaling mechanisms to prevent neuronal
damage in AD. Our central hypothesis posits that CHI3L1, derived from astrocytes, functions as a signaling
molecule that mediates inflammatory responses in a manner specific to different cell types, ultimately promoting
neuronal degeneration and regulating microglial inflammatory profiles. Importantly, we also hypothesize that by
silencing CHI3L1 signaling in neurons, we can mitigate neurotoxicity and ameliorate AD pathology. To dissect
the complex interactions between brain cell types, we plan to utilize to iPSC-based cultures consisting of pure
and mixed populations of human microglia, astrocytes and neurons. Furthermore, we will leverage our unique
transgenic mouse strains with astrocyte-specific CHI3L1 conditional knockout to rigorously test our hypothesis.
To accomplish the overall objectives, we will pursue the two specific aims: Aim 1 is to investigate how CHI3L1
induces neuronal apoptosis and neurodegenerative changes through interactions with receptors on neurons and
microglia, by using iPSC-based neural culture systems to dissect the neuroprotective role of CHI3L1 and inspire
the development of anti-neuroinflammatory therapeutics; Aim 2 is to determine the translational potential of
targeting CHI3L1 signaling for neurodegeneration in AD, by manipulating astroglial expression of CHI3L1 and
its identified neuronal receptor to remedy brain pathology and behavioral defects in AD-relevant mouse models.
The expected outcomes of this study include defining a CHI3L1-mediated signaling mechanism that
governs neurodegeneration in AD pathogenesis. This work is highly significant and innovative as it aims to
elucidate the biological role of CHI3L1, a prominent AD biomarker. By understanding the involved molecular and
cellular functions of CHI3L1, this study could pave the way for new treatments for AD and relevant disorders.

Public health relevance
PROJECT NARRATIVE This proposed research is relevant to public health because defining the regulatory role of CHI3L1 for neuroinflammation in health and in disease not only greatly advance our knowledge on the non-neuronal contributions to the pathogenesis of Alzheimer’s disease (AD) but also present a proof of principle for forthcoming translational studies focusing on neuroinflammation underlying neurodegeneration. Developing strategies which target neuroinflammation to improve clinical outcome and alleviate disease impact are important as they are broadly applicable to a wide range of neurodegenerative disorders in addition to AD. Thus, this proposed research is relevant to the part of NIH’s mission that pertains to reducing the burdens of human disability.